IRACDA at Tufts University

Project Summary
The goals of the Tufts IRACDA program, which began in 2019, are to provide a diverse pool of recent Ph.D.
scientists with comprehensive postdoctoral training that prepares them for impactful academic careers in the
biomedical sciences and to increase the involvement of under-represented groups in biomedical research. To
accomplish this, the program provides a unique, scaffolded four-year training experience, with postdocs
spending 75% of their time conducting research and the other 25% in career development activities, including
a mentored teaching experience at three minority-serving partner institutions in the Boston area - Bunker Hill
Community College, University of Massachusetts-Boston, and Suffolk University. The program will admit 4 new
scholars each year, for a steady-state total of 16 scholars supported by their research mentors for the first year
and IRACDA the next three. Tufts IRACDA training emphasizes foundational skills needed to establish an
independent and rigorous research program, obtain external funding, mentor early-career scientists, and
develop and deliver innovative courses that engage students from all backgrounds. An additional goal of Tufts
IRACDA is to enhance the classroom and research experiences of students at our partner institutions. Through
regular interactions with these students both in and out of the classroom, our scholars will encourage them to
seek training and research opportunities that prepare them for biomedical science careers. Tufts IRACDA will
also promote research collaborations between Tufts and partner faculty that will lead to joint publications, grant
applications, and the development of Course-based Undergraduate Research Experiences (CUREs) at the
partner schools to expose more partner students to the scientific process. To keep our programming current
and responsive to participant needs, we seek continuous feedback from our scholars, research mentors, and
partner institutions. In the most recent cycle, we identified areas for improvement through surveys and
interviews, and have developed new programming and partnerships that allow each scholar to better tailor
individualized training for the type of academic career they are pursuing. Program outcomes, including scholar
publications and placements, along with the impacts for our partner schools, are regularly monitored with the
assistance of an advisory committee and an external evaluation team, and program adjustments are
implemented to ensure that the outcomes match or exceed our targets for success. We have also initiated a
collaboration with 5 other IRACDA programs to develop a tool to better document partner impact and share
best practices. In summary, our proposed program will ensure that Tufts IRACDA scholars are well-prepared to
succeed as faculty at a variety of academic institutions, while making a strong contribution to the scientific
future of our nation and enhancing the diversity of the biomedical workforce.

Public health relevance
Project Narrative The Tufts IRACDA program provides comprehensive postdoctoral training for outstanding scientists who seek academic careers that combine cutting-edge research, teaching, and mentoring, while ensuring that our nation’s biomedical workforce is diverse. The structured training program provides scholars with tools needed to establish independent research programs, develop and deliver cutting-edge courses rooted in best pedagogical practices, and mentor diverse groups of students. By building teaching and research partnerships with three local institutions that serve students from a variety of racial, ethnic, and socioeconomic backgrounds, Tufts IRACDA will inspire the next generation of scientists and provide them with opportunities and experiences to launch impactful careers.